Air Pollution and Cognitive Function

ABSTRACT
Fine particulate matter air pollution has been found to be associated with increased inflammation, respiratory
disease, cardiovascular event risk, and cognitive changes and risk for Alzheimer’s Disease and Related
Dementias (ADRD). Prior research has established that those exposed to higher levels of air pollution have
higher levels of accumulated amyloid-beta (Aβ) and tau in frontal cortex at autopsy, higher error rates on
cognitive function assessments, and lower scores on memory and both verbal and non-verbal intelligence
assessments. In the US, exposure to high levels of air pollution is common, with substantial heterogeneity that
is often associated with socioeconomic and racial/ethnic differences. Most research on the health effects of air
pollution is based on outdoor ambient air quality measurements often supplemented by monitoring. This
methodology cannot address contributions from indoor air quality and mobility in daily life, has limited
geospatial precision, and cannot address individual differences in exposure and contextual factors (e.g., time
spent indoor vs. outdoor, proximity to pollution sources, smoking, antiquated heating materials, and floor levels
in buildings. This exposure misclassification likely results in significant biases towards the null in the estimation
of the effects of air pollution. Commercially available, validated, wearable air quality sensors can accurately
characterize person-specific air pollutant exposures to better understand how they relate to ADRD, and these
will be used to assess exposure in this project. This Project, part of a renewal of the Einstein Aging Study
(EAS; NIA P01 AG003949), will follow 767 diverse participants aged 60+ (dementia free at baseline) for up to 5
annual waves of data collection, collecting person-specific indices of exposure to fine particulate matter air
pollution (PM1, PM2.5) to investigate the association of fine particulate matter exposure with cognition function
and AD/ADRD (Specific Aim 1), biomarkers of neurodegeneration and vascular brain pathology (Specific Aim
2), and social determinants of health (Specific Aim 3). Establishing the association of person-specific air
pollution exposure with momentary cognitive function, a biological pathway for that association, and how this
association is modified by social determinants will yield insight into individual susceptibility and resilience to
acute and chronic environmental stressors.

Public health relevance
PROJECT NARRATIVE This study will collect person-level data on exposure to fine particulate matter (PM1, PM2.5) air pollution. Those data will be used to study the effects of this pollution on cognition and risk for Alzheimer’s Disease and Related Dementias (ADRD), biomarkers of AD/ADRD, and social determinants of health.